Evaluating the Use and Impact of Telemedicine Among Latina Women of Reproductive Age with Type II Diabetes

PROJECT ABSTRACT
Latina women of reproductive age are disproportionately affected by type II diabetes. From 1996 to 2014, Latina women
experienced a 125.2% increase in age-adjusted prevalence of pregestational type II diabetes compared to only 13.6% for
non-Latina White women. Women with pregestational diabetes experience worse maternal and neonatal outcomes.
This is driven by biological, cultural, and social factors, including, including access to care. Preventing maternal and infant
health complications requires close follow-up in the pregestational period. By extending care beyond the clinic,
telemedicine presents an opportunity to address these challenges. Telemedicine offers patients video and telephone
visits from remote settings. It presents an opportunity to increase access to care and potentially improve care for Latina
women of reproductive age with type II diabetes. The goal of this supplement to my K23 parent grant is to address this
critical need by to evaluating the uptake, use, and impact telemedicine on diabetes outcomes for Latina women of
reproductive age with type II diabetes. My central hypothesis is that by applying rigorous and innovative statistical and
machine learning approaches we can identify disparities in access to telemedicine among Latina women of reproductive
age with type II diabetes and assess the impact of telemedicine on diabetes outcomes. The proposed project will test the
central hypothesis with the following 3 specific aims. Aim 1 will examine the access and use of telemedicine among
Latina women of reproductive age with type II diabetes. Aim 2 will assess the impact of telemedicine on glycemic control
among Latina women of reproductive age with type II diabetes. Aim 3 will utilize an unsupervised machine learning
approach to detect latent subgroups based on patient demographic, clinical, and social factors and then evaluate their
clinical applications in telemedicine use. Through the application of advanced biostatistical and machine learning
methods supported by community engagement, this proposal addresses overlapping health information technology and
diabetes disparities among Latina patients of reproductive age with type II diabetes.
The proposed research is complemented by a rigorous training plan and a highly experienced mentorship and
collaboration team that will ensure my completion of this supplement. The training plan focuses on biostatistical
research methods, machine learning, and mentorship skills. This proposal will further support my K23 which forms the
basis for an R01 application centering on a larger clinical trial testing the effect of the implementation intervention on
clinical outcomes among Latino patients with diabetes.

Public health relevance
PROJECT NARRATIVE Latina women of reproductive age have a high burden of type II diabetes leading to worse health outcomes. Telemedicine has the potential to improve diabetes outcomes but has been understudied in this population. To inform telemedicine implementation strategies and improve care, the proposed research will identify gaps in telemedicine uptake and use and assess the impact of telemedicine on glycemic control among Latina patients of reproductive age with type II diabetes.